Unraveling skin microbiota-immune interactions that drive early life commensal tolerance

Research Project Summary
The skin is a vital barrier tissue, which manages to maintain immune homeostasis amidst ongoing microbial
stimulation. Cutaneous immune cells continually sense skin commensal microbes, yet a healthy symbiosis is
preserved through mechanisms that actively regulate this commensal-specific immune response. Disruption of
this tolerance contributes to chronic inflammatory diseases such as acne vulgaris, atopic dermatitis and
hidradenitis suppurativa. Prior work from my lab has highlighted that early exposure to skin bacteria promotes
immune tolerance through the generation of commensal-specific regulatory T cells (Tregs). Recent studies
specifically identified CD301b+ type 2 dendritic cells (DC2) as the primary population sampling commensal
bacteria in neonatal skin and critically supporting generation of commensal-specific Tregs. The Treg-promoting
function of CD301b+ DC2 is facilitated by their retinoic acid production, which is further augmented upon
uptake of commensal bacteria. However, many questions remained from this work, most notably, what are the
commensal signals that reinforce tolerogenic function in CD301b+ DCs and how are these sensed? Preliminary
data I’ve generated since starting my PhD have started to address this knowledge gap. I have shown that in
vivo deletion of toll like receptor 2 (TLR2) leads to greatly reduced commensal-specific Tregs in neonatal mice.
Additionally, through in vivo and ex vivo studies using mutant Staphylococcus epidermidis strains, I have seen
that fewer commensal-specific Tregs are generated by CD301b+ DC2 in response to bacteria lacking D-alanine
modification of their surface teichoic acids, known ligands for TLR2. Collectively, these results shed new light
on the role of conserved microbial ligands not only as stimulators of cutaneous immune defense against
pathogens but also as fundamentally supporting commensal-specific immune tolerance. Building on these solid
lines of evidence, this project will investigate how TLR2 sensing of modified ligands on commensal
Staphylococcus spp. supports Treg induction by CD301b+ DC2s. Aimed at dissecting these mechanisms and
furthering my training goals, I will employ a combination of approaches, including transgenic mouse models,
genetic manipulation of bacterial strains, and human skin explants. Collectively, these studies will deepen our
understanding of skin immune tolerance, potentially inform therapeutic targets for inflammatory diseases and
advance me towards my long-term career goal of becoming an independent investigator and academic
educator studying host-microbe interactions.

Public health relevance
Project Narrative Immune homeostasis is especially important and notably complex at body barrier sites such as skin that undergo continual stimulation by commensal microbes. Early life is a critical time for development of commensal-specific regulatory CD4+ T cells which promote skin immune homeostasis, yet it remains unclear which specific microbial components and immune receptors are necessary to initiate this long-lived tolerance. This project will investigate how toll-like receptor 2-mediated sensing of Staphylococcus spp. cell wall ligands by skin dendritic cells promotes early life establishment of commensal-specific tolerance.